ACTG395--INDINAVIR IN COMBINATION W/ STAVUDINE &LAMIVUDINE IN HIV INF CHILDREN

ACTG 395 (and associated protocol Merck 068) evaluates the combination of indinavir (an antiretroviral of the protease inhibitor class) with two nucleoside transcriptase inhibitors (stavudine and lamivudine) in HIV infected children ages 3-18 years. This study closed to accrual of new patients in November, 1998, and we anticipate that treatment and data collection for this study will be extended until at least late 1999 to allow patients to remain on study medications while the FDA reviews the data. No preliminary data are available at this time.